4D MOUSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Keywords: Volume data analysis, visualization and distribution, collaboration Abstract: Johnson's group has collected a number of gated micro-CT studies on the mouse cardiac cycle, including the effect of number of scans and the amount of dye given to the mouse. In order to analyze this data, the PSC volume browser will be modified to allow for the efficient viewing of 4D (3D volumes varying over time) and the ability to support analysis tools as plug-ins, server-side modules, and as stand-alone packages.